Postpartum Depression and Parenting: Role of mPOA circuits in maternal sensitivity

Project Summary
Maternal behavior that is sensitive to the needs of the offspring is essential for healthy development and
emotional wellbeing in humans; yet the neural circuits and neurobiological mechanisms that allow such dynamic
coordination are not well understood. Our prior work in rats demonstrates that the medial preoptic area (mPOA),
a critical node in the circuitry regulating maternal behavior, plays an essential role in this critical maternal ability
(referred to here as maternal sensitivity), allowing mothers to promptly and flexibly adjust caregiving behaviors
to resolve the constantly changing needs of their offspring. Postpartum depression is a serious health problem
affecting women and their babies worldwide, often with tragic implications for the new mother’s ability to
sensitively care for her child. Our overall objective is to provide much-needed mechanistic insight into the
neurobiological mechanisms by which maternal sensitivity is compromised by postpartum depression. To
achieve this goal, we will use intersectional viral strategies and leverage the many strengths of the Wistar-Kyoto
(WKY) animal model of depression for molecular, circuit-level and behavioral analysis. Our previous work
demonstrated that WKY mother rats exhibit a syndrome of behavioral deficits relative to control strains that
closely model major clinical features of postpartum depression, including disturbances in maternal sensitivity.
This proposal builds on our previous findings by examining how mPOA neurons that project to the infralimbic
cortex (mPOAàIL, AIM 1) and the ventral tegmental area (mPOAàVTA, AIM 2), contribute to maternal
sensitivity. Both structures receive direct input from the mPOA and have long been implicated in cognitive and
motivational aspects of goal-directed behaviors, including parenting and depression. The first group of
experiments will use combined injections of a Cre-dependent inhibitory (hM4Di) or excitatory (hM3Dq) designer
receptors exclusively activated by designer drugs (DREADD) into the mPOA, with a retrograde transducing
CAV2-Cre virus into the IL or VTA to assess the functional necessity and sufficiency of these pathways for
maternal sensitivity. We will also use GCaMP6s combined with CAV2-Cre to selectively monitor the activity of
mPOAàIL and mPOAàVTA neurons while WKY and control mothers interact with offspring with varying needs.
Considering the consequences of impaired maternal sensitivity on both mother and child health, it is of major
clinical significance to understand the neurobiology contributing to this critical maternal ability. This proposal will
generate critical new knowledge on how the brain computes dynamic modifications in need signals to generate
sensitive patterns of maternal behavior.

Public health relevance
Project Narrative Maternal behavior that is sensitive to the needs of the offspring is essential for healthy development and emotional wellbeing in humans, yet the brain mechanisms that allow mothers to flexibly attend to the constantly changing needs of their offspring are not well understood. Postpartum depression is one of the most prevalent and severe mental illnesses affecting women and their babies, and is of serious public health concern because of its tragic impact on parenting, especially maternal sensitivity. The proposed studies represent the first preclinical investigation of the neurobiological mechanisms that are altered in postpartum depression and lead to disturbances in maternal sensitivity.